Characterizing Cannabis Use and its Impact on Smoking Cessation Among Socioeconomically Disadvantaged Adults Participating in Smoking Cessation Treatment

This application is being submitted in response to the Notice of Special Interest (NOSI) identified as NOT-
CA-22-070, Administrative Supplements for Examining Patterns of Tobacco and Cannabis Use. The prevalence of
cannabis use is elevated among adults who smoke, and particularly among those with low socioeconomic status.
However, the impact of cannabis use on smoking cessation remains unclear. The proposed administrative
supplement will leverage an ongoing smoking cessation intervention trial for low-income adult smokers
(R01CA251451) to collect new data to characterize baseline and daily cannabis and tobacco use and co-use patterns,
compare cannabis users and non-users on respiratory symptoms and mental/physical health, and evaluate the impact
of cannabis use on daily smoking and point prevalence smoking abstinence at post-quit follow-up. Data from 135
adults enrolled in the ongoing parent trial will be included in the proposed analyses, to be completed within the 1-year
supplement time frame. All participants will provide information about their tobacco and cannabis use at baseline, prior
to initiating smoking cessation treatment, and they will complete smartphone-based assessments of their expired
carbon monoxide (CO), self-reported tobacco and cannabis use, and other relevant factors over a 7-week period (1-
week pre-quit day through 4 weeks post-quit, and during post-quit weeks 8 and 12). Follow-up assessments of CO-
verified 7-day point prevalence smoking abstinence will focus on follow-ups at 4, 8, and 12 weeks post-quit to fit within
the 1-year supplement time frame. The supplement will address the following specific aims: 1) Characterize cannabis
use characteristics among low-income adults participating in tobacco cessation treatment, including a) baseline and
daily prevalence, frequency, intensity, and modalities of cannabis use (e.g., combusted vs. non-combusted) as well as
reasons for use, b) baseline cannabis dependence severity and harm perceptions, c) daily prevalence of tobacco and
cannabis co-use assessed via smartphone-based daily diaries, and d) interest at baseline and follow-up in reducing or
abstaining from cannabis use; 2) At baseline, compare past 30-day cannabis users with non-users on
sociodemographic characteristics, tobacco use history, physical and mental health, alcohol use, respiratory
symptoms, exposure to cannabis secondhand smoke, expired CO levels, and cigarette dependence; 3) Evaluate the
within-day and distal relationships between cannabis use and smoking cessation, including: a) the relation between
baseline cannabis use (past 30-day use vs. non-use) and smoking cessation outcomes at follow-up (4, 8, and 12
weeks post-quit), b) the within-day relations of cannabis use with cigarette craving, withdrawal symptom severity, and
smoking during the weeks following a scheduled quit attempt via smartphone-based assessments, and c) the relation
of cannabis use frequency (i.e., near daily use, days of use) during the first 4 weeks following a scheduled smoking
quit attempt with CO-verified point prevalence smoking abstinence at follow-ups. Findings will yield important
information about the impact of cannabis use during smoking cessation treatment, and identify factors that can be
targeted in cessation interventions.

Public health relevance
Although the prevalence of smoking has declined overall in the U.S., smoking rates remain higher among socioeconomically disadvantaged adults. The prevalence of cannabis use is elevated among adults who smoke, and particularly among those with low socioeconomic status. The primary objective of the proposed study is to characterize cannabis use among low-income adult smokers initiating smoking cessation treatment, and to evaluate the impact of cannabis use on cessation with the goal of improving tobacco cessation treatment and reducing smoking-related cancers.